State-of-the-art High Field 7T MRI System Upgrade to Accelerate Translational Sciences

SUMMARY - ABSTRACT
This S10 application is requesting funds to support a major upgrade to a state-of-the-art 7T small-animal Bruker
Biospec MRI instrument that serves as the high-field, small-animal MRI system on the Northwestern University
Feinberg School of Medicine (FSM) Chicago campus. The system was purchased over 10 years ago using funds
from an NIH S10 award and has served as a key imaging instrument for preclinical biomedical research at the
Northwestern imaging core facility (Center for Translational Imaging, CTI) for many NIH funded investigators. It
has been a heavily used, highly-productive, and indispensable as a key discovery tool for basic and translational
biomedical sciences. However, after >10 years of service, the 7T imaging equipment at Northwestern is an aging
and outdated system and its performance limits ongoing research projects. In addition, the current type of high-
field 7T MRI system (Bruker ClinScan) is no longer supported by the vendor (Bruker no longer provides
upgrades, maintains hardware, or services the system in a satisfactory way), creating a particularly problematic
scenario for reliable operation for ongoing and future small animal studies. To address this unmet need, we seek
funding for the modernization our existing instrument to a state-of-the-art preclinical high field 7T MRI system
(upgrade to 7T Bruker Biospec, including enhanced gradients, multi-channel transmit/receive capability, and
advanced imaging sequences for increased versatility of supported imaging applications).
The 7T MRI system upgrade will provide reliable modern equipment to allow the existing users to continue their
successful preclinical research programs. Based on past usage and active NIH funded projects, the projects of
the 16 Major Users would require approximately 82% of available time for use of the instrument, while the Minor
Users would occupy 8% and the remaining would be available for exploratory research and testing of new
preclinical imaging applications. The requested 7T MRI upgrade was tailored to the needs of userbase 1) by
ensuring access to a reliable and serviceable small animal imaging instrument, and 2) by providing new imaging
capabilities that are highly relevant to their preclinical research projects (e.g., multi-channel transmit/receive RF
coils for improved SNR, B1 homogeneity and parallel imaging; enhanced gradients for improved imaging speed;
dynamic filed map shimming; advanced MRI sequences, independent gradient cooling).
There is strong institutional support for the 7T MRI system modernization and upgrade, as documented by a
track record of continuous logistic and financial support for the small animal imaging instrumentation over the
past decade. Location of the upgraded state-of-the-art high-field 7T MRI equipment in a well-established
Northwestern imaging core facility with an existing small animal PET-CT system, small animal holding, and
human MRI systems will allow for a sustained continuation and future expansion of Northwestern preclinical
biomedical research activities.

Public health relevance
PROJECT NARRATIVE This proposal requests support for a new state-of-the-art high-field Magnetic Resonance Imaging (MRI) system on the Northwestern University Feinberg School of Medicine Chicago campus. There is a large established user based and strong institutional support for the 7T MRI system modernization, as documented a track record of major NIH funding as well as dedicated administrative, operational, and financial commitments for the small animal imaging instrumentation over the past decade. Location of the MRI equipment in a well-established Northwestern core facility (CTI) with other existing imaging modalities, small animal holding, and human MRI systems will support immersive, collaborative, and cutting-edge preclinical imaging studies, and allow for a sustained continuation and future expansion of Northwestern preclinical biomedical research activities.